Accurate and Individualized Prediction of Excitation-Inhibition Imbalance in Alzheimer's Disease using Data-driven Neural Model

Accurate and Individualized Prediction of Excitation-Inhibition Imbalance in
Alzheimer’s Disease using Data-driven Neural Model
Project Summary/Abstract
Alzheimer’s disease (AD) is the most common form of dementia characterized by progressive and irreversible
cognitive decline. Despite its devastating impacts on the US health care system, its precise etiology and effective
treatment options are still lacking. Recent animal studies and human neuroimaging data indicate disrupted
excitation-inhibition (E-I) balance in AD which may serve as important pathophysiological and therapeutic target.
However, existing analytical techniques in functional MRI (fMRI) do not allow for E-I mapping at cellular and
circuit levels. To overcome these limitations, we have developed a Multiscale Neural Model Inversion (MNMI)
framework based on resting-state fMRI (rs-fMRI) and diffusion MRI (dMRI) to detect circuit-level E-I imbalance
in neuronal networks underlying disease conditions. The goal of this project is to validate and refine the
MNMI framework for accurate and individualized estimation of E-I imbalance in AD.
To achieve this goal, we will pursue two specific aims. In Aim 1, we will predict disrupted E-I balance in an AD
mouse model using MNMI of rs-fMRI. We will first perform ZTE-fMRI and dMRI on wild-type (WT) control and
3xTg-AD (TG) mice. We will then apply the MNMI model to predict regional E-I balance based on rs-fMRI and
dMRI and derive areas with E-I impairments in AD mice. Based on MNMI predictions we will select four brain
regions (three with the most significant E-I impairments in TG mice plus one control region) for in vivo optical
measurements. In Aim 2, we will validate the MNMI model predictions using in vivo optical E-I measurements
and behavioral testing. We will first perform simultaneous ZTE-fMRI and fiber photometry (at the four selected
sites) in a different set of age-matched WT and TG mice as Aim 1. We will then validate the model predictions
at both individual subject and group levels and improve the MNMI framework if model predictions deviate from
empirical E-I measures. Lastly, we will examine if the E-I imbalance in TG mice is associated with cognitive
impairments. The overarching goal of our research is to combine computational modeling, fMRI, and
cutting-edge neuromodulation and recording tools to delineate pathological network activity, elucidate
the underlying circuit mechanisms, and develop more effective treatment modalities for AD. Successful
implementation of this project will lead to an innovative computational framework that serves to identify
pathological E-I imbalance using noninvasive MRI and facilitates the development of new diagnostic technique
and personalized treatment for detecting and restoring E-I imbalance in early intervention. The proposed work
is also of broader significance to the fields of neuroscience, neuroimaging, psychiatry, and psychology since
novel tools will be developed to enable the identification of E-I balance in health and imbalance in diseases.

Public health relevance
Project Narrative / Public Health Relevance Statement The improvement of public mental and neurological health is closely knit to health knowledge generated through neuroscience research and application of relevant research findings in community settings. The validation and refinement of a computational framework for accurate and individualized prediction of excitation-inhibition imbalance in Alzheimer’s disease using noninvasive MRI will promote early diagnosis and personalized treatments for detecting and restoring E-I imbalance in early intervention. The validated computational framework can be easily extended and applied to study pathological mechanisms of other neurological and psychiatric disorders.